Defining the features of T cell response to tumor and self-antigens as predictors of response to checkpoint therapy

PROJECT SUMMARY/ABSTRACT
Immune checkpoint inhibitor therapies have revolutionized the field of solid tumor oncology - in particular, they
have played a substantial role in improving the survival of patients with advanced lung or bladder cancer.
However, despite clinical successes, immune checkpoint inhibitors are not effective in all cases, and may be
associated with serious immune-related adverse events. This application is in response to the National Cancer
Institute’s Provocative Question #8: “What are the predictive biomarkers for the onset of immune-related adverse
events (irAE) associated with checkpoint inhibition, and are they related to markers for efficacy?” The goal of the
proposed studies is to identify T cell biomarkers that predict autoimmune-related irAE associated with ICI
therapy. The central hypothesis for the proposed studies is that the frequency and phenotype of T cells
specific for self-antigens predicts autoimmune irAE, which in turn predicts therapeutic efficacy in some
patients. The following four Specific Aims will address this hypothesis. Aim 1 studies will determine how immune
checkpoint inhibitor therapy alters the frequency and phenotype(s) of tumor- and autoantigen-specific T cells
using an innovative approach to isolate antigen-specific T cells, and a longitudinal cohort of subjects before and
after immune checkpoint inhibitor therapy. Aim 2 studies will use an innovative single cell RNA-sequencing
approach to determine if expanded T cell clones arise with immune checkpoint inhibitor therapy, and whether
these T cells have phenotypic or functional properties predictive of anti-tumor and autoimmune responses. Aim
3 studies will determine whether immune checkpoint inhibitor therapy alters the CD4 and CD8 T cell landscape
in cancer making it similar to that seen in individuals with natural autoimmunity. Aim 4 studies will test the
hypothesis that immune checkpoint inhibitor therapy releases quiescent autoreactive T cells from regulation,
leading to increased frequency and activation distinct from the global T cell response. Together, these studies
will systematically elucidate the relationship between tumor- and auto- immunity following immune checkpoint
inhibitor therapy, and will provide insight into the potential of T cell biomarkers to predict clinical outcome.

Public health relevance
PROJECT NARRATIVE Immune checkpoint inhibitors are drugs that have revolutionized the treatment of lung and bladder cancer as well as other cancer types. Despite their success at improving patient survival, they do not work in all patients and often have serious side effects. The goal of this project is to identify biomarkers that predict immune checkpoint inhibitor efficacy and/or side effects.